Sexual Dimorphism in the Striatum Underlying Pathophysiological Consequences of Striatal Abnormalities

ABSTRACT
Sexual dimorphism in the prevalence and presentation in neuropsychiatric disease is common, but the
mechanisms underlying this dimorphism remain unclear. Neurodevelopmental diseases such as autism
and Tourette’s syndrome (TS) are diagnosed at a 3 to 5 times more often in males than females,
suggesting an underlying dimorphism in brain circuitry and/or in pathophysiology. The basal ganglia
circuitry, and in particular pathology of interneurons in the striatum, is implicated in many
neuropsychiatric disorders, including autism and TS. We have previously described a system in which we
depleted specific interneurons in the striatum, including cholinergic interneurons (CINs) and fast spiking
interneurons (FSIs), in the mouse striatum. We made the startling observation that ablation of striatal
interneurons produces dysregulated activity in the basal ganglia network and a range of behavioral
effects – loss of social preference, anxiety-like behavior, and repetitive motor pathology – but only in
male mice, not in females. This parallels the sexual dimorphism seen in patients with autism and TS. This
mouse striatal interneuron depletion system provides a unique opportunity to probe the mechanistic
underpinnings of sexual dimorphism in basal ganglia function and pathology, and to delineate
mechanisms that may contribute to dimorphism in human neuropsychiatric disease.
To this end, we propose three Specific Aims. Our first Aim examines sexual dimorphism in healthy adult
striatal circuitry, characterizing interneuron number, morphology, connectivity, and synaptic protein
density through immunohistochemistry and biochemical methods. Our second Aim will examine sex-
specific gene expression differences through RNA-seq bioinformatic analysis of striatal tissue and
RNAscope analysis of specific neuronal subtypes. Our third Aim seeks to characterize the female-specific
mechanism(s) that buffer the development of striatal circuit dysregulation and behavioral abnormalities
following depletion of striatal CINs and FSIs in female mice. Here, we will test specific candidate
mechanisms, grounded in our own and others’ pilot investigations.
We hypothesize that baseline sexual dimorphism in striatal physiology and function underlies the sexual
dimorphism in pathological circuity activity and behavioral changes following striatal interneuron
depletion. An understanding of this innate dimorphism in mice may ultimately provide insight into the
differential incidence and symptomology in males and females of human neuropsychiatric conditions
characterized by basal ganglia dysfunction.

Public health relevance
PROJECT NARRATIVE Sexual dimorphism in prevalence and presentation is common to many neuropsychiatric diseases, including autism and Tourette syndrome, that are characterized by interneuron deficiency in the basal ganglia. To further our understanding of this sexual dimorphism, we will investigate baseline differences in the striatum in between male and female mice as well as investigate mechanisms behind behavioral differences in mice with interneuron depletion in the striatum, which previous work has shown to produce striking changes in brain activity and in behavior in males, but not in females. A better understanding of innate differences in striatal circuitry and function and of and the sexually dimorphic response of brain and behavior to interneuron depletion may provide insight into the differential prevalence and presentation of neuropsychiatric diseases affecting this circuitry in males and females.